INTRON A VS INTRON A + RIBAVIRIN IN RELAPSED HEPATITIS C

This study addresses the efficacy and safety of interferon alpha-2b compared to interferon alpha-2b and Ribavirin in untreated hepatitis C patients. The biochemical and virological response to treatment are measured at two time points: at the end of treatment and six months posttreatment sustained response. Secondary endpoints include improve- ment in liver biopsy at posttreatment (based on the sum of Knodell scores I+II+III), time to response and time to relapse. This randomized clinical trial continues and no preliminary results are available. Future studies will focus on a long-acting form of pegylated interferon in conjunction with ribavirin.